Engineering S. typhimurium for metastatic colorectal cancer

The engineering of living cells and microbes is driving a new era of cancer therapy. This transformative approach
allows for the genetic programming of living cells to intelligently sense and respond to environments, ultimately
adding specificity and efficacy that is otherwise unattainable with molecular-based therapeutics. Due to recent
microbiome studies indicating the prevalence of bacteria within the human body and specifically in tumor tissue,
bacteria have generated significant interest as cancer therapies. Additionally, a multitude of empirical studies
have demonstrated that administered bacteria home and selectively grow in tumors due to reduced immune
surveillance of tumor cores. Given their presence and selectivity for tumors, bacteria present a unique oppor-
tunity to be engineered as intelligent delivery vehicles for cancer therapy.
The objective of this proposal is to engineer and optimize S. typhimurium for metastatic colorectal cancer
therapy. Since animal based-testing regimes limit the rate of clinical progress, we will use a high-throughput,
bacteria-spheroid platform to rapidly test therapeutic payloads and production and release strategies. We will
also assess the effect of therapies on colorectal genetic backgrounds, and investigate spatio-temporal hetero-
geneity in 3D spheroids with the use of engineered cell reporters. We will then test lead candidates in mouse
models of primary and metastatic colorectal cancer to evaluate safety and efficacy. We will focus on colorectal
cancer due to several proof-of-concept studies from our lab demonstrating efficacy in colorectal spheroids and
animal models. In particular, we showed that oral delivery of bacteria can specifically colonize colorectal liver
metastases, providing an attractive delivery route as a cancer therapy. Since these metastases are often con-
fined to the liver, this approach can have a significant impact on tumor growth and survival. The research in this
proposal will help to establish a framework to genetically engineer microbes for cancer therapy, and significantly
accelerates tools that will impact the broader cancer and synthetic biology communities. If successful, future
lead candidates for potential clinical trials will be identified on the basis of therapeutic efficacy and safety studies
from this proposal.

Public health relevance
The engineering of living cells and microbes is a transformative approach to cancer therapy, as cells can be genetically programmed to intelligently sense and respond to environments potentially leading to improved safety and efficacy of therapies. However, the vast number of rapidly engineered therapies far outpaces the throughput of animal-based testing regimes, thus creating a major bottleneck for clinical translation. Leveraging synthetic biology tools and a high-throughput bacteria-spheroid platform, the objective of this proposal is to rapidly optimize tumor-homing S. tyhpimurium to express therapeutics locally and specifically in tumors.